Xenbase: a Xenopus Model Organism Knowledgebase

Component: OVERALL
PROJECT SUMMARY/ABSTRACT
Xenbase is the Xenopus Model Organism Knowledgebase (MOK), an online resource that
integrates all genomic and biological data from Xenopus research. Our mission is to accelerate
the translation of Xenopus research into knowledge that will improve human health. We aim to
empower Xenopus research and enhance the impact of Xenopus data in the broader biomedical
community, as animal models, such as Xenopus, are essential for biomedical research and
have led to a wealth of discoveries. Xenbase is user-friendly, allowing investigators to quickly
find and link different data types in ways that would otherwise be difficult, time consuming, or
impossible. It provides high quality curation, data integration, and bioinformatics tools to link
Xenopus data to humans and other model organisms, NCBI, UniProt, Ensembl and other
resources. In this post genomic era, with thousands of scientific publications annually, and the
exponential growth of “omic” datasets, Xenbase is essential to translate the enormous amount
of data generated from research using Xenopus into meaningful connected data. Xenbase,
thus, plays an essential role in maximizing NIH’s >$120 million annual investment in Xenopus
research. Xenbase is an essential resource for hundreds of labs around the world. There is a
clear need to continue curating Xenopus data, to develop new tools to keep up with
technological advances, and link Xenopus data to human biology in novel and insightful ways.
Many of the letters of support (more than 110) state that labs could not function without
Xenbase, and renewed funding for Xenbase was identified as the top priority in the 2020
Xenopus research community white paper.

Public health relevance
Component: OVERALL PROJECT NARRATIVE Xenbase is the Xenopus model organism knowledgebase (MOK), an online resource that integrates all genomic and biological data from Xenopus research. Our mission is to accelerate the translation of Xenopus research into knowledge that will improve human health.